CORE--CELL BIOLOGY LABORATORY

The Cell Biology Core provides Program Project investigators and their supporting staff with technical support and consultation in cell culture development, preparation and experimental design, immunohistochemistry, ELISAs and molecular biology techniques. The Core occupies dedicated laboratory space within the Division of Bone and Mineral Disease at Barnes-Jewish Hospital North. The Cell Biology Core is responsible for the screening and purchasing of serum and the preparation of the various media required to prepare, culture and maintain the numerous cell lines carried in the main laboratory and available for use by the investigators in each project of the Program to carry out their individual experimental protocols. Careful quality control measures have been taken to insure that media and sera are supportive of cell growth and continual attempts made to offer the investigators the "most appropriate, i.e. osteoblastic phenotype, and homogenous cell" cultures. To continue pursuing the development of techniques and procedures which will ultimately satisfy the continued need for viable bone marrow, phenotypic rat and human osteoblasts and human bone marrow stromal cells and osteoclast-like cells, and multiple cell lines of human and rodent origin, the basic organization of the Core has been expanded. In order to support and service the experimental protocols described in the application which are targeted to: 1) examine bone cell differentiation and communication via cell adhesion; 2) examine the control of osteoclast activation and differentiation; 3) examine cell matrix response to mechanical loading; and 4) examine osteoclast-mediated bone remodeling, new technical support is proposed for the present renewal. To accomplish this goal, we plan new endeavors in the Cell Biology Core including technical support in the areas of: (1) immunohistochemical analysis of osteoblast development, expression of specific membrane proteins and osteoclast function; (2) analysis of cell culture supernatants for cytokines by ELISA; (3) providing services for the development, preparation and/or maintenance of new cell lines, and 4) providing a centralized area for molecular biology procedure. Based on current and projected usage, we expect that the Core resources will be extensive utilized nd that demands for our services to grow.